Use of novel fluorescent tracers to develop a comprehensive retinal biomarker database that maps the heterogeneity of Alzheimer's pathogenesis

Project Summary
Alzheimer’s disease (AD), the most common form of dementia, has traditionally been defined by the
accumulation of amyloid beta (Aβ) in neuritic plaques and hyperphosphorylated tau in neurofibrillary tangles.
However, recent evidence indicates that AD is better viewed as a continuum of disease with a broader degree
of mechanistic and pathological heterogeneity. For example, ~15% of AD patients are negative for Aβ and most
AD patients have “mixed pathology”, with large subsets exhibiting accumulation of additional neurodegenerative
biomarkers such as α-synuclein (α-syn) and the TDP-43. Hippocampal and amygdalar deposits of TDP-43 have
recently been characterized as defining a disease state that overlaps heavily with AD: Limbic-predominant, Age-
related TDP-43 Encephalopathy (LATE). At present, AD diagnosis relies on clinical evaluation of symptoms and
PET imaging of Aβ and Tau load. However, this is costly, involves exposure to radiation, and does not have the
ability to detect broader dimensions of AD heterogeneity, such as the presence of pathological α-syn and TDP-
43 deposits that define large subsets of the AD continuum. There is an unmet medical need for an antemortem
diagnostic that can reliably identify mechanistic heterogeneity in individual AD patients, ideally one that can
detect multiple disease-related biomarkers simultaneously and non-invasively in CNS tissue. Amydis is
leveraging the retina as a “window to the brain” to address this unmet need by developing an ocular contrast
agent – i.e. a “retinal tracer – that can be used to fluorescently label α-syn, TDP-43, and Aβ in patients suspected
of having AD. The retinal tracer, AMDX-2011P, currently in human clinical trials, has these remarkable
capabilities and is designed to have fluorescent properties amenable for use with standard retinal imaging
equipment found in the eye care office, making this technology widely accessible. In this proposal, Amydis will
take the first clinical steps towards developing transformative new diagnostic technology in AD focusing on the
biomarker Aβ in AD patient retinas. The specific aims of the project are: (1) to develop a lyophilized product of
AMDX-2011P for i.v. delivery; (2) to complete a Phase 1B clinical trial of AMDX-2011P in patients with a clinical
diagnosis of FAD (known FAD mutation and dementia) who have a positive Aβ PET scan (N=12), subjects with
known FAD mutation but without clinical evidence of dementia (N=12) and healthy subjects (N=8) to determine
if the tracer reliably reports on Aβ status; and, (3) to begin constructing a database of AD and normal retinal
images for use in developing automated, AI-assisted retinal biomarker analytics tools for physicians and
researchers. Completion of these aims will advance the development of our in vivo ocular diagnostic test, getting
us one step closer to our mission of providing an antemortem, simple, and affordable diagnostic to parse the
heterogeneity of AD. Future studies will integrate knowledge obtained from ongoing clinical studies of AMDX-
2011P as a marker of a-syn and TDP-43 and assess whether the tracer can report on the co-occurrence and
variability of these critical biomarkers in individual patients.

Public health relevance
Project Narrative Alzheimer’s disease (AD), the most common form of dementia, is increasingly appreciated as a mechanistically heterogeneous condition in which variations in the accumulation of amyloid beta, alpha-synuclein and TDP-43 may define pathophysiologically distinct subsets of patients. Creating new diagnostic modalities to measure these biomarkers in CNS tissue is critical to developing novel, disease-modifying therapeutics for AD and applying them with precision in the AD population. The proposed study is the first clinical step in leveraging the eye as a “window to the brain” by advancing a novel retinal tracer that can image these biomarkers in retina for non-invasive, affordable and widely accessible diagnostic assessment of heterogeneity in the Alzheimer’s spectrum.